Contributions of Hepatic and Intestinal Pathways to Cholesterol Excretion

7. Project Summary
Reverse cholesterol transport (RCT) is the process by which excess cholesterol is eliminated from the
body. Disruptions in RCT contribute to a variety of metabolic diseases including atherosclerosis, insulin
resistance and non-alcoholic fatty liver disease (NAFLD). The ABCG5 ABCG8 (G5G8) sterol
transporter facilitates sterol secretion in the hepatobiliary and transintestinal pathways. Our new data
indicate that G5G8 is indispensable in opposing dietary cholesterol accumulation, however, the relative
contribution of hepatic vs. intestinal G5G8 in opposition cholesterol accumulation is unknown. Despite
its discovery over 20 years ago, little known about the post-translational regulation of the transporter.
We've recently developed key biological reagents and approaches that will allow for the investigation
of endogenous G5G8 post-transcriptional regulation. Preliminary experiments revealed several
surprises. 1) G5G8 is localized to an intracellular compartment in vivo and in polarized hepatocytes. 2)
G5G8 translocates to the apical domain in response to stimulation with the intestinal hormone FGF15/19
in vivo. 3) G5G8 is degraded in lysosomes following heterodimer formation. We hypothesize that
hepatic G5G8 is post-translationally regulated to promote biliary cholesterol secretion but
dependent on intestinal G5G8 to prevent dietary cholesterol accumulation, mechanisms that are
disrupted by clinical variants that contribute to MetS phenotypes. Aim I will determine molecular
mechanisms of G5G8 post-translational regulation in vitro and in vivo. We will interrogate the
biosynthetic itinerary and steady state distribution of the G5G8 heterodimer in WIF-B polarized
hepatocytes. The sub-apically located structures in which it resides in unstimulated cells will be
identified. Apical translocation in response to stimuli of biliary cholesterol secretion (bile acids,
FGF15/19, etc.) will be determined and results confirmed in vivo. These studies will be replicated with
human G5G8 expressed in liver-specific G5G8-deficient mice. Aim II will determine the impact of
hepatic and intestinal G5G8 on cholesterol excretion. Control and mice and lacking G5G8 in liver,
intestine or both organs will be challenged with cholesterol-containing diets. Plasma and fecal sterols
and measures of RCT will be analyzed. Hepatic gene expression and metabolic phenotypes including
insulin sensitivity and measures of NAFLD will be assessed. Aim III will investigate the impact of human
variants of ABCG5 and ABCG8 on basal and bile acid-stimulated biliary cholesterol secretion using
novel adenoassociated viral vectors and tissue-specific G5G8-deficieny mice. We will also investigate
the effect of these variants on the development of obesity-related phenotypes in response to
cholesterol-containing diets.

Public health relevance
Project Narrative Disruptions in biliary cholesterol secretion increases risk for chronic metabolic diseases including insulin resistance, nonalcoholic fatty liver disease, and atherosclerosis. This project investigates the mechanisms by which the G5G8 cholesterol transporter is regulated and opposes metabolic disease.